Bridging Research Gaps: Building Capacity for Measuring and Addressing Intimate Partner Violence (IPV) in Maternal Health Research

Project Summary/Abstract
Maternal mortality is a pressing global issue, especially impacting vulnerable populations. Intimate partner
violence (IPV) is a widespread problem that significantly intersects with maternal health, leading to adverse
outcomes and an increased risk of maternal mortality. Homicide, often committed by intimate partners, is the
primary cause of death during pregnancy, with the highest risk among Black and adolescent populations.
Despite its importance, addressing IPV in maternal mortality research remains an underdeveloped aspect of
public health research. This R25 grant proposal seeks to bridge this gap by developing a comprehensive
research education program to equip maternal health researchers with the essential skills to effectively
measure and address IPV in their research. Our program will be developed following the ADDIE (Analyze,
Design, Develop, Implement, and Evaluate) Model of Instructional Design and is organized into three distinct
aims. In Aim 1, we will build upon our prior work to develop a webinar-based curriculum focused on four core
areas essential for effective measurement of IPV in maternal health research: (1) understanding the scope and
impact of IPV, (2) IPV measurement characteristics and tools, (3) analysis and interpretation of IPV data, and
(4) cultural safety in maternal health and IPV research. We will also develop an online resource toolkit with
webinar recordings, IPV measurement tools, sample protocols, and ethical guidelines. Aim 2 will involve
implementation of the research education program in an online synchronous format, delivered through two
webinars lasting 2 hours each. We will offer the education program four times during the 2-year grant period,
with the first offering serving as a pilot. We aim to enroll 10-12 participants in the pilot and 20-25 in each
subsequent offering. We will extend the reach of our curriculum through the dissemination of our online
resource toolkit, ensuring wide access and sustainability beyond the funding period. Aim 3 will involve a
comprehensive evaluation of feedback obtained from our Advisory Board, comprised of experts and
stakeholders (formative evaluation); the implementation of proposed activities (process evaluation), and the
overall effectiveness of the activities in achieving the aims of the training program (outcome evaluation). The
outcome evaluation will be guided by Kirkpatrick’s Four Levels of Training Evaluation to assess participants’
satisfaction, learning, behavior, and results. By evaluating the program's impact and refining it accordingly, the
team aims to strengthen the program's efficacy over time, ensuring that it remains relevant and effective in
addressing IPV in maternal health research and supporting the needs of researchers in the field. Empowering
maternal health researchers with these tools will enhance their capacity to generate translatable evidence-
based solutions, thus strengthening the ability of health professionals to provide comprehensive care and,
ultimately, contribute to the reduction of maternal mortality and IPV among vulnerable populations.

Public health relevance
Project Narrative Despite the clear link between intimate partner violence (IPV) and adverse maternal health outcomes, including maternal mortality, IPV is understudied in maternal health research. This R25 grant proposal seeks to bridge this gap by developing, implementing, and evaluating a comprehensive web-based research education program and resource toolkit to equip maternal health researchers with the essential skills to effectively measure and address IPV in their research. Empowering maternal health researchers with these skills will build their capacity to generate translatable evidence-based solutions to address the intersection of IPV and maternal health, thus strengthening the ability of health professionals to provide comprehensive care and, ultimately, contributing to the reduction of maternal mortality and IPV among vulnerable populations.